Research Education Component

Project Summary – Research Education Component
The overwhelming burden of suffering, disability, and years of life lost due to Alzheimer’s disease (AD) and
AD-related dementias (AD/ADRD) represent a global crisis. Hispanic Americans are at higher risk for
AD/ADRD and less likely to receive care and participate in research and service efforts designed to decrease
health disparities in AD/ADRD than their non-Hispanic White counterparts. This is particularly evident among
Hispanic Americans residing in the Rio Grande Valley (RGV), an area classified as persistent poverty and
medically underserved, where the prevalence of dementia is among the highest in the country.
Reaching and studying this population requires culturally-attuned and appropriately-trained investigators who
are prepared to advance social, behavioral, and community-engaged research with translational impact. There
is an equally great concomitant need to diversify the AD/ADRD research workforce, increasing representation
of members of the many communities, identities, races, ethnicities, backgrounds, abilities, cultures and beliefs,
including underserved communities, that make up the American people. The AD/ADRD-RCMAR’s Research
Education Component (REC) at the University of Texas RGV (UTRGV) puts into place a comprehensive
research education program with two overarching objectives: 1) to prepare a diverse body of early-career
junior faculty to grow into enduring careers as successful research scientists, and 2) to contribute in an
impactful way to the body of knowledge on health disparities in AD/ADRD among the growing US Hispanic
population, particularly aging Mexican Americans, along the Texas-Mexico border in the Rio Grande Valley
and South Texas. The REC will leverage the research expertise and resources of experienced, successful,
interdisciplinary investigators and leaders in these fields to achieve the following specific aims: (1) Identify and
support innovative pilot projects, focused on social or behavioral problems, aspects, or correlates of AD/ADRD
in minority populations. (2) Support the continued development of pilot project grant recipients as researchers.
(3) Provide training in grant preparation, administration, and budgeting. (4) Provide a series of
didactics/seminars on: a) Health disparities research survey; b) AD/ADRD-RCMAR Cores and key unique
research resources and their potential application to AD/ADRD health disparities research; c) AD/ADRD
research in Texas; and d) responsible conduct of research. (5) Provide continued mentoring. To accomplish
these goals, we have built a leadership team with extensive experience in research education, planning and
evaluation of mentoring, and leadership of collaborative interdisciplinary research efforts aimed at improving
minorities' and Hispanics' health in targeted geographic populations, and we have accounted for all needed
administrative and logistic support. Trainees and mentees will engage in and benefit from a rich immersive
experience in developing collaborative research addressing social and behavioral contributors to AD/ADRD
and its impacts in the poverty-stricken, primarily Hispanic US-Mexico border region of the RGV.